Developing HTS assays for identifying NLK activators to target Huntington's disease

Project Summary
Huntington’s disease (HD) is caused by the mutation of the Huntingtin (HTT) gene, which encodes the
mutant huntingtin protein (mHTT) with an expanded polyglutamine tract (polyQ). The gain of toxic
function of mHTT is the major cause of HD. Lowering mHTT may provide an effective approach in
treating HD by ameliorating its downstream toxicity. If successful, this strategy may modify disease
progression in human HD. In fact, lowering of HTT levels by a variety of genetic approaches has been
shown to effectively mitigate mHTT toxicity in HD models. However, genetic approaches still face
significant challenges in effective delivery to the affected brain regions of HD patients. Thus, small
molecule compounds that can lower mHTT levels are highly desired to treat HD. Cellular mechanisms
promoting mHTT clearance are of great interest in modifying HD pathology because they can lower the
levels of the mHTT protein and resultant toxic species, thus affecting disease progression. Ubiquitination
can direct mHTT for clearance through two major protein clearance pathways - the ubiquitin-proteasome
system and autophagy. Nemo-like kinase (NLK) is an evolutionarily conserved serine/threonine kinase
and expressed at relatively high levels in the central nervous system. We found that NLK levels are
significantly decreased in HD postmortem brains. We further demonstrated that NLK interacts with HTT
and lowers endogenous mHTT levels in a kinase-dependent manner in human cells. Overexpression of
NLK in the mouse striatum attenuates HD pathology, whereas genetic reduction of NLK levels
exacerbates the neuropathology in HD mice. Furthermore, we discovered that NLK enhanced mHTT
ubiquitination, indicating that NLK may facilitate mHTT degradation. Our preclinical results strongly
support that NLK has a neuroprotective role in modifying disease progression and is a potential novel
drug target to lower mHTT levels. In Aim 1, we will develop two complementary high-throughput
screening (HTS) assays to identify NLK activators, including an in vitro enzymatic-based HTRF assay
and a cell-based BRET assay to monitor NLK homodimerization. In Aim 2: We will conduct a pilot HTS
campaign for NLK activator and hit confirmation using a library of 9900 CNS focus compounds.

Public health relevance
Project Narrative Huntington’s disease (HD) is caused by the mutation of the Huntingtin (HTT) gene. Currently, there is no cure for this devastating disease. We aim to develop high-throughput screening assays and screen of nemo like kinase (NLK) activators to provide a novel mechanism and candidate compounds for treatment for HD.